Precision single-cell mapping of chromatin-associated protein activity by molecular footprinting to chart disruptions to gene regulation and dissect tumor heterogeneity in cancer

ABSTRACT
Single-cell analysis has transformed biomedical research, revolutionizing our understanding of biological
processes while providing invaluable insight into human physiology and disease, including cancer. However,
current single-cell methodologies are largely restricted to analyzing DNA or RNA features, with analysis of the
crucial regulatory protein activity layer remaining almost completely unexplored from the single-cell perspective,
with current technologies only able to profile the most stable chromatin-binding factors such as histones in single
cells. This has led to significant gaps in our knowledge about mechanisms of gene regulation in both normal and
tumor cells, and has further prevented the development of potential precision therapies that could target
pathways that are dysregulated in cancer development or progression. Therefore, the ability to assess the activity
of regulatory proteins with different DNA-binding affinities, including weak or transient factors that are critical for
transcription regulation, at the single-cell level would open up a new era in the field, similar to the single-cell
RNA-seq revolution. To address this challenge, we will pioneer the development of new transformative methods
for high-throughput single-cell mapping of DNA-binding proteins across binding affinities to define genome
regulation, as well as dysregulation, in human cancer. We present Docking & Deamination plus sequencing
(D&D-seq) for direct single-cell DNA footprinting, which tethers a species-specific antibody-binding nanobody to
a cytosine base editing enzyme, catalyzing C-to-U edits in proximal genomic regions reflecting target binding to
DNA. Combined with single-cell ATAC-seq, this approach enables high-throughput profiling of even weak factor
binding to DNA in single-cells using common sequencing platforms. To develop D&D-seq for high-throughput
analysis of single-cell gene regulation in cancer, we will optimize profiling across high- and low-affinity binders,
and engineer a variety of molecular footprinting base editors to map multiple functional DNA:protein interactions
in tumor cells. To capture gene regulation across different layers in the same cell, we will incorporate D&D-seq
into common single-cell multi-omics workflows to profile transcription factor (TF) binding and chromatin
accessibility together with gene expression and protein levels or histone modifications in single cells for the first
time. To better assess the effects of cancer-associated somatic mutations on gene regulatory networks, we will
integrate D&D-seq with our single-cell genotyping framework to identify TF binding patterns that are specific to
mutant cells. Finally, to support wide adoption by the single-cell cancer genomics community, we will adapt D&D
for split-and-pool barcoding, enabling high-thoughput, multimodal analysis of gene regulatory networks in
hundreds of thousands of single cells without requiring specific sequencing platforms. Together, these methods
will enable the direct single-cell measurement of DNA:protein interactions and TF activity in native chromatin
contexts to empower novel discoveries about chromatin dynamics and transcriptional regulation in human tumor
cells at unprecedented resolution, opening up entire new fields of inquiry that were unable to be pursued before.

Public health relevance
PROJECT NARRATIVE Single cells are the fundamental unit of human biology, and understanding the mechanisms of gene regulation at the level of the single cell is crucial for defining dysregulation in cancer, as well as for identifying new targets for the development of more effective anti-tumor therapies. Although recently there have been incredible advances in single-cell sequencing methods, due to technical limitations we currently lack approaches that are capable of directly mapping all the regulatory protein factors that bind to DNA to enact gene expression programs at the single-cell level, leaving a significant gap in our knowledge of the gene regulation landscape and how this is altered in cancer cells. To address this challenge, here we develop high-throughput methods to map single- cell DNA:protein interactions together with other genetic, chromatin, histone or transcriptomic features to accurately define gene regulatory networks in single cells, which can be leveraged to chart cellular dysregulation at unprecedented detail in human tumor cells.